The development of genetically-based pathways underlying problematic alcohol use - Supplement

PROJECT SUMMARY/ABSTRACT
The purpose of this administrative supplement is to support Dr. Wang’s transition from a mentored career
development K01 award to research independence in the face of her upcoming critical life event. This
supplement support will help ensure continuity of Dr. Wang’s research during this critical juncture in her career
by providing funds to support a statistical coordinator. Together with funds from the parent award, this statistical
coordinator will be available on a full-time basis to help Dr. Wang with phenotypic and genetic data management,
manipulation, and analysis during and following her planned time off and amidst her increased caregiving
responsibilities. This extra support is particularly important for Dr. Wang’s project, which primarily involves
secondary analysis of high dimensional datasets and requires considerable expertise to be moved forward. This
supplement support would come during a sensitive time in Dr. Wang’s career and thus would have a meaningful
influence on her retention in biomedical research and transition to full research independence. Indeed, she will
be preparing to submit her first applications for R01 funding during the supplement period. Dr. Wang will benefit
from additional statistical effort towards manuscript submissions and plans for a successful R01 submission and
transition to an independent research career.

Public health relevance
PROJECT NARRATIVE - No change from original Discovering unique, biologically-based pathways to problematic alcohol use (ALC) will help us tailor interventions for this condition. This proposal will examine patterns by which adolescent risk factors for ALC are inherited in families to identify new genetically-based traits; these traits could lead us to discover novel individualized treatment targets for ALC. Testing sex differences in these new genetically-based traits and their relation to ALC will shed light on whether differing treatments are needed for males and females.